Driving forces of membrane protein assembly in membranes

ABSTRACT
Membrane proteins are responsible for controlling the passage of nutrients, waste, energy and information in
and out of cells. They are critical players in physiology and key targets for pharmacological regulation, however,
we lack a fundamental understanding of why these proteins are thermodynamically stable in cell membranes.
Simply put, why does a greasy protein surface find its greasy protein partner in the greasy lipid bilayer to
assemble faithfully into its stable, native structure? In order to investigate this question, the Robertson laboratory
has developed a robust and rigorous model system to study equilibrium protein association in membranes based
on the reversible dimerization of the CLC-ec1 Cl-/H+ antiporter. Through the development of fluorescence and
single-molecule microscopy approaches, it is now possible to experimentally conduct a full thermodynamic
analysis of the CLC dimerization reaction in lipid bilayers, yielding the free energy of association (ΔG°) and free
energy changes (ΔΔG) due to mutations or different lipid conditions. Recent advances have allowed us to study
CLC equilibrium as a function of temperature, enabling a van 't Hoff analysis to dissect the thermodynamic
changes in enthalpy (ΔH°) and entropy (ΔS°) upon dimerization. In addition, we have developed methods for
measuring equilibrium kinetics of CLC dimerization in a tractable manner - in the membrane and in real-time.
With this foundation in place, the Robertson lab is primed to build a full molecular model of CLC dimerization in
membranes. In the next phase of this project, we will investigate the hypothesis that CLC subunits are driven to
associate due to differential solvent dependent driving forces in the associated and dissociated states, and that
the transition state involves a critical solvation/de-solvation step. We will investigate this along three distinct
aims, by building a theoretical model of the CLC dimerization free energy in membranes using computational
approaches (Aim 1), connecting the CLC sequence and structure to dimerization through experimental
measurements of thermodynamics and kinetics (Aim 2), and developing a guest-host approach to experimentally
and theoretically quantify the impact of mixed lipid composition on protein association equilibria in membranes
(Aim 3). Throughout each of these studies, we integrate experiments and theory hand-in-hand, enabling us to
make robust connections between physical driving forces and molecular mechanisms. Regardless of the validity
of our hypothesis, our studies will provide meaningful quantitative information to the study of membrane proteins
in membranes. Ultimately, we expect that the results from these studies will provide a foundation for the field to
build new strategies for targeting membrane protein stability and mis-folding based on fundamental physical
principles.

Public health relevance
NARRATIVE The proper assembly of membrane proteins is of critical importance to cellular physiology, yet we do not have a fundamental understanding of the physical reasons why membrane proteins form stable assemblies in the hydrophobic membrane. In this project, we will study the equilibrium dimerization reaction of the CLC-ec1 Cl- /H+ antiporter as a model system to dissect the thermodynamic driving forces underlying membrane protein association in lipid bilayers. The results from this study will identify the molecular mechanisms for how protein sequence, lipid composition and general anesthetics modulate stability, and thereby lay down a physical foundation for the development of new strategies aimed at correcting stability defects in membrane protein folding diseases.